Michigan Collaborative Hub for TMD Patient-Centric Research (MICH T PCR)

ABSTRACT
Temporomandibular disorders (TMD) are a significant public health and societal problem that manifests itself in
pain, compromised joint and overall function, and affecting up to 10% of the population. Since pain frequently
occurs with a plethora of mostly subjective symptoms, TMD are frequently misdiagnosed and treatments are
frequently non-standardized and ineffective. While investments in TMD research have been made over the
past several decades, there has been limited success in translating such research to the clinic. Likewise, the
heterogeneity in symptoms and complexity of a disease that impacts the joint, muscle, and nervous systems,
complicates the understanding of disease etiology and mechanisms, and impairs the development of evidence-
based therapies. As a result, basic and clinical research on TMD are frequently divorced from one
another, with insufficient linkages between basic discoveries and clinical needs. To advance basic,
clinical, and translational TMD research in an integrated manner, we will establish an interactive, multi-
disciplinary team at Michigan in partnership with the clinical practice community as a means of
forming a patient-centered collaborative ecosystem. The goal of our IMPACT program is to transform the
treatment of TMD patients through the translation of clinically-relevant innovations. Our vision is to integrate
life science, engineering and health technologies to solve clinically-defined problems in a translational
infrastructure environment. Herein, we will develop an organizational structure, ecosystem and operational
procedures for establishing a consortium that integrates basic and clinical research in TMD and guides the
most promising research toward translation in an evidence-based manner to improve clinical care. To achieve
this vision, we leverage the experience and leadership of the NIDCR center program in regenerative medicine
(DOCTRC) at Michigan to guide our planning of how to best catalyze basic research through the translational
pipeline and into the clinic. In this R34, we will design the structure and develop an implementation strategy for
the future TMD collaborative via the following aims: 1) Develop a multi-disciplinary organizational structure
and processes to inform basic and patient-centered research that yield a mechanistic understanding of TMDs
and development of diagnostics and therapies suitable for translation to clinical practice. 2) Integrate diverse
teams that support the collaboration of basic and clinical research and processes for selecting research
themes and projects that can be translated into clinical practice. 3) Formulate operating procedures to
support the clinical translation of innovative TMD technologies and therapies. Upon completion of the aims, we
will be uniquely positioned to advance basic and clinical TMD research, research training, and translation to
evidence-based treatments leading to a transformation in TMD care.

Public health relevance
PROJECT NARRATIVE Temporomandibular disorders (TMD) are a significant public health and societal problem that manifests itself in pain, compromised joint and overall function, and affects up to 10% of the population. We will establish an interactive, multi-disciplinary team at Michigan to form a patient-centered collaborative ecosystem to advance basic and clinical TMD research, research training, and translation to evidence-based treatments leading to a transformation in TMD care.